Virus-like Particle based malaria vaccines targeting vulnerable epitopes in the circumsporozoite protein

PROJECT SUMMARY
The Plasmodium falciparum circumsporozoite protein (CSP) is an attractive malaria vaccine candidate because
anti-CSP antibodies can block liver invasion and potentially provide sterilizing immunity against the parasite.
However, current vaccines that target CSP, including RTS,S, the most advanced malaria vaccine, elicit
suboptimal protective immunity that wanes dramatically over time. In this proposal, our goal is to engineer new
and more effective vaccines targeting CSP. We will take advantage of the recent identification of potently
protective monoclonal antibodies that target epitopes within novel sites of vulnerability in CSP. We will
specifically target these epitopes using a highly immunogenic bacteriophage virus-like particle (VLP) vaccine
platform technology. In preliminary data, we have shown that VLP-based immunogens targeting short epitopes
within CSP can elicit high-titer and long-lasting antibody responses that inhibit Plasmodium infection of the liver
and can prevent blood-stage infection in mice. In this proposal, we will utilize an arsenal of approaches to
maximize the immunogenicity of VLP-based vaccines (Aim 1), we will use sensitive techniques to carefully
monitor the B cell responses to our vaccines (Aim 2), and we will measure the effectiveness of vaccines in a
state-of-the-art mouse infection model (Aim 3). Our team, which has expertise in vaccine engineering and design,
B cell immunology, and malaria challenge models, will carry out these Aims with the ultimate goal of identifying
a pre-erythrocytic malaria vaccine candidate suitable of advancing to clinical trials.

Public health relevance
PROJECT NARRATIVE Malaria caused by the parasite Plasmodium falciparum is a major threat to global public health. In this project, we will engineer prophylactic malaria vaccines that target the pre-erythrocytic stage of the malaria lifecycle by targeting vulnerable epitopes in the circumsporozoite protein using a virus-like particle (VLP)-based vaccine platform.